Achieving challenging coupling with gold redox catalysis

Project Summary/Abstract Transition metal catalyzed cross coupling is one of the most important strategies in complex molecule synthesis. This approach has been widely applied in medicinal and biological research for drug candidate preparation and for biological target modification/functionalization. Despite the great successes during the last two decades, there are remaining challenges that need to be addressed. The three problems in coupling type transformations that we would like to address in this proposal are A) controlling selectivity on cross coupling while alkynes are involved, B) increasing the efficiency of forming large macrocycles through catalytic coupling process, and C) extending the choice of coupling partners, such as amine and F-­, as compatible functional groups for coupling type transformations. The general scheme of the proposed research is the ligand-­assisted gold redox catalysis, recently developed from PI’s lab. Compared with the conventional coupling methods, gold chemistry offers some unique reactivity, including fast reductive elimination, selective formation of gold acetylide and ligand-­assisted diazonium activation through nitrogen extrusion. These properties provide new opportunities to address some of the long-­existing challenges in metal catalyzed cross coupling. The proposed research is innovative because it focuses on the impact of new reactivity offered by this recently developed Au(I)/Au(III) redox catalysis toward challenging C-­C and C-­X coupling transformations. These investigations are also significant and will advance pharmaceutical and medicinal research by providing new strategies to achieve complex molecule synthesis.

Public health relevance
Project narrative: The proposed investigations from the Department of Chemistry at University of South Florida focus on the development of novel catalytic systems for challenging C- C bond forming transformations, which are significant for biological and medicinal research by assisting drug candidate discovery for critical disease treatment.